Framework for radiomics standardization with application in pulmonary CT scans

PROJECT SUMMARY / ABSTRACT
Radiomics, or imaging biomarkers, are an active area of research and development that is increasing in breadth
with more widespread access to large, patient image databases. Radiomics models have been applied in a wide
range of diagnostics, classification tasks, and disease scoring; with advantages for efficient radiology workflow,
reducing errors and highlighting important features, and providing additional information in challenging diagnostic
cases. Accuracy of radiomics is dependent on a number of factors. The variability associated with the imaging
chain including the particular imaging device/vendor, acquisition protocol, data processing, etc. is undesirable
and can have a dramatic effect on a radiomics model’s performance. Successful radiomics models generally
require careful data curation and standardization of protocols – often preventing successful or efficient modeling
in large aggregations of patient data across institutions, vendors, etc. Moreover, even with careful attention to
protocol, many imaging devices, like x-ray computed-tomography CT have patient- and scan-specific image
properties that continue to add undesirable variability to a radiomics computation. In this work, we propose a
framework for end-to-end modeling of a CT imaging system – integrating radiomics calculations as an
explicit stage and imaging system output. This kind of rigorous modeling extends previous efforts to under-
stand and control the performance of imaging systems. In this context, the proposed mathematical framework
provides not only a mechanism for prediction of radiomics values based on the various system depend-
ences that degrade their accuracy; but also informs recovery approaches to estimate the underlying “true”
radiomics based on the underlying biology uncorrupted by the particular image properties (noise/resolution) of
the patient image. We hypothesize that this new paradigm for radiomics computation will both standardize met-
rics and improve quantitation. We will test these hypotheses and apply standardization methods to radiomics for
interstitial lung disease (ILD, an application where lung textures provide substantial diagnostic information about
the disease) through the following specific aims: Aim 1: Develop a mathematical framework for radiomics
standardization, wherein both predictive “forward” models and “inverse” recovery models for ILD radiomics will
be developed, characterized, and evaluated. Aim 2: Apply and validate prediction and standardization
framework in physical systems using custom phantoms with lung textures and including a series of investiga-
tions on well-characterized CT benches and CT scanners from all major vendors. Aim 3: Investigate the impact
of standardization on radiomics modeling performance in clinical CT data. A multi-site study will establish
the performance of standardized radiomics using the proposed framework in radiomics models for both regional
and whole lung characterization. Successful completion of these aims will establish a new paradigm for stand-
ardized radiomics computation that is applied and validate in multi-site data. This opens the doors to larger, more
diverse imaging datasets and the potential for more efficient recovery of subtle imaging biomarkers.

Public health relevance
PROJECT NARRATIVE Radiomics models, or imaging biomarkers, have been proposed to allow automatic computer-aided diagnosis, classification, and scoring of various diseases based on imaging study data. Radiomics research and development is a rapidly growing field with the increasing availability of large imaging databases and access to sophisticated software and modeling tools; however, successful radiomics models typically require careful data curation and understanding to limit variability associated with the imaging chain (in contrast to the desired variability in the underlying patient anatomy which contains the target biomarkers). This work seeks to provide a rigorous mathematical framework with models for predicting the undesirable variability associated with the imaging device, acquisition protocol, and data processing; as well as strategies for standardization across those dependencies to rigorously estimate the underlying imaging biomarkers, thus permitting high-performance radiomics model development and application across a broad range of data sources.